PROJECT 2: Imaging sex differences in stress-related neurochemical mechanisms of alcohol use disorders

It is increasingly clear that women are more vulnerable than men to some of the negative effects of chronic
alcohol consumption, including immune system dysfunction and neurodegeneration. This is important since the
rates of problem drinking in women are rapidly increasing, and the currently available treatments are only
moderately effective. There is mounting evidence that men and women drink for different reasons. Women
tend to drink to regulate stress and negative affect, whereas men report drinking for alcohol-related positive
reinforcement. This provides an important opportunity to explore sex-appropriate treatments. In particular, we
need to understand the neurochemical mechanisms that underlie and contribute to these behavioral sex
differences in order to provide new treatment targets for medication development. In this proposed Yale-
SCORE, Project 2 will focus on identifying sex differences in biomarkers of alcohol-induced neurodegeneration
that lead to neural adaptations that drive the addiction cycle. Using state-of-the-art positron emission
tomography (PET) technology, we will examine sex differences in levels of microglia and synaptic density in
living individuals with alcohol use disorder (AUD). Microglia, the brains’ resident immune cells, are involved in a
variety of physiologic and pathologic processes, most notably surveying the brains’ environment for danger
and carrying out necessary repair functions. Alcohol initially activates microglia but chronic consumption has
been shown to suppress both peripheral and neuroimmune systems. We have preliminary data suggesting
more severe neuroimmune suppression in women vs. men with AUD, which may underlie the findings that
women with AUD exhibit worse mood and neurocognitive dysfunction than men. Microglia are also critical for
supporting synaptic structure and function and conversely, microglial dysfunction leads to deficits in synapse
number and contributes to mood and cognitive impairment. However, the relationships between microglia,
synaptic density, stress, mood, and neurocognitive function in living humans with AUD are not known. In the
current study, we will examine whether chronic alcohol consumption is associated with reductions in microglia
(Aim 1) and synaptic density (Aim 2) and if the impairment varies by sex. We hypothesize that women with
AUD evidence greater deficits in microglia and synaptic density, which underlie sex differences in stress
reactivity, negative affect, and neurocognitive dysfunction in AUD (Aim 3). Thus, the proposed project has the
potential to measure, for the first time, sex differences in neurochemical markers of neurodegeneration in the
living brain of patients with AUD and their relationship to critical clinical outcomes. These findings will advance
the alcohol field by uncovering novel, sex-appropriate treatment targets.

Public health relevance
In the United States, approximately 33 million men and women have an alcohol use disorder (AUD) and their alcohol use has devastating consequences on their health and mental well-being, with women suffering greater consequences than men. Current treatments for AUD show only minimal efficacy. This research contributes to the public health effort by identifying neurochemical mechanisms, including microglia and synaptic density, that underlie the sex differences in alcohol-related dysfunction, informing novel sex-appropriate therapeutic approaches.